Expression and Function of Cone Pigment Genes

DESCRIPTION (provided by applicant): The long-term goal of this research program is to understand the role of amino acid sequence polymorphisms in the long- and middle-wavelength cone opsins in vision disorders. All known amino acid substitutions observed in human rhodopsin or in the human S cone opsin are associated with photoreceptor abnormalities and disease. The question we will address in this proposal is - what is the role of amino acid substitutions in the L and M cone opsins in vision disorders? We propose the following specific aims: Specific Aim 1: Examine the relationship between cone opsin variants and age related macular degeneration (AMD). Using DNA samples from several hundred subjects with AMD and several hundred matched control subjects we will quantify the association between sequence variations in the L and M opsin genes and risk of AMD. Specific Aim 2: A high frequency opsin variant, designated LVAVA, has never been observed in a male with normal vision. Its occurrence is always associated with vision disorder. Individuals with this variant exhibit pathological myopia, cone ERG abnormalities and optic nerve hypoplasia indicating a reduced number of ganglion cells. We will examine the effects of the LVAVA variant on the structure and physiology of cone photoreceptors and other retinal cells in a mouse model and determine the mechanism by which the variant opsin produces its wide spectrum of abnormalities in the eye. Specific Aim 3: A second cone opsin variant which is never observed in males with normal vision, designated LIAVA, is generated at a high rate. Function is disrupted in cones expressing this variant and adaptive optics imaging demonstrates that cones expressing it are damaged or lost. We will examine the effects of the LIAVA mutation on the structure and physiology of cone photoreceptors in a mouse model and determine the mechanism by which the variant opsin disrupts photoreceptor function.